Novel therapy to prevent alveolar bone loss in severe periodontitis

Novel therapy to prevent alveolar bone loss in severe periodontitis
Abstract
Periodontal disease affects almost half of US adults 30 years and older. More advanced disease,
periodontitis, leads to retraction of the gums from the teeth, with loss of alveolar bone, and ultimately loss of
teeth. A key step in progression of periodontitis involves the loss of alveolar bone that provides the underlying
support for the tooth. This process is mediated by bone-degrading osteoclasts (OC). Osteoclast activation by
inflammatory mediators disrupts bone homeostasis, leading to loss of bone mass. OC differentiation from OC
progenitor cells (OCP) is modulated by a cascade of integrated signaling culminating in stimulation by RANKL
that ultimately leads to fusion of OCP to form the active, multinucleated OC. While multiple fusogens, including
the dendritic cell-specific transmembrane protein (DC-STAMP) and CD9, are recognized, recent data suggest a
pivotal role for OC-stimulatory transmembrane protein (OC-STAMP). OC-STAMP knock-out mice exhibit
diminished alveolar bone loss in a standard ligature-induced model of periodontitis. Unlike anti-DC-STAMP, anti-
OC-STAMP down-regulates expression of CD9. These studies of osteoclastogenesis involving OC-STAMP
suggest a potential therapeutic intervention for periodontitis using an anti-OC-STAMP monoclonal antibody.
Proof-of-concept work utilized a murine-specific anti-OC-STAMP murine monoclonal antibody. During this Phase
1 project, we will identify and evaluate a panel of human anti-human OC-STAMP monoclonal antibodies. A lead
antibody will be identified using a ligature-induced periodontitis model in a human OC-STAMP knock-in mouse
model. This work will produce a novel therapeutic to slow or even potentially halt loss of alveolar bone and teeth
in severe periodontitis.

Public health relevance
Narrative Periodontal disease affects almost half of Americans 30 years and older. Advanced periodontal disease leads to retraction of the gums from the teeth and ultimately loss of teeth. A key step in progression of periodontitis involves the loss of alveolar bone that provides the underlying support for the tooth. This process involves the bone-degrading cells, whose importance in periodontitis is now recognized. We have identified a novel approach to halt the destruction of bone and to prevent tooth loss.